Detection of Disease Progression in Advanced Glaucoma

A pressing unmet need in the field of glaucoma diagnostics is to find methods for objective detection of
disease worsening or prediction of visual field (VF) progression in eyes with advanced disease. Eyes with
advanced glaucoma are at high risk of losing the remaining vision and blindness. Retinal nerve fiber layer
(RNFL) and optic nerve head measures reach their measurement floor as glaucoma progresses beyond the
early stages. Hence, functional assessment of the central VF is currently the main tool for monitoring advanced
glaucoma. Our central hypothesis is that assessment of the macular retinal ganglion cell (RGC)/axonal
complex can lead to improved detection or prediction of disease progression since the last RGCs to disappear
in glaucoma reside in the central retina (the macula). We will test this hypothesis in a cohort of glaucoma
subjects just reaching 5 years of follow-­up and validate our methods in separate cohorts of glaucoma and
normal subjects. Aim 1. Are macular thickness measures able to detect change earlier and with a stronger
signal compared to RNFL measures in advanced glaucoma? We will measure progression rates for global and
local macular and RNFL measures within a Bayesian hierarchical framework. We will compare progression
rates and the proportion of progressing eyes/regions/sectors for macular and RNFL measures to normal eyes
and account for differing scales, age-­related decay, and treatment. Aim 2A. Can macular OCT thickness
changes confirm and predict changes in central VFs for advanced glaucoma? We will estimate
longitudinal/temporal structure-­function relationships with Bayesian joint hierarchical longitudinal modeling of
macular OCT and central 10° VF measures. These models will determine whether there is a contemporaneous
or lagged deterioration of OCT and VF. We will assess the influence of baseline disease severity, treatment
and other covariates on these joint longitudinal models. We will also compare the joint macular/central VF
models to joint models of RNFL and 24° VFs and develop functional prediction models from 1 to 4 years
ahead. Aim 2B. To validate the performance of prediction models, we will initiate a second prospectively
enrolled cohort of patients meeting similar inclusion criteria and matched to the original cohort by age, gender,
ethnicity and baseline glaucoma severity. We will compare VF point predictions (e.g., one-­ or two-­visit step
ahead) to the observed VF data. Aim 3. Develop software for combining macular structural and functional data
in real time as a clinical tool for detection or prediction of progression. It will provide clinicians with
structural/functional rates of change and structural ‘step’ changes from baseline, and the probability and
distribution of predicted functional changes The information provided by the application can be used during a
clinical encounter to make decisions regarding ongoing management of glaucoma. Widespread real-­time use
of our software will result in significant improvements in disease monitoring and timely treatment of progressive
glaucoma through advanced stages and will help reduce visual disability from glaucoma.

Public health relevance
Project Narrative Eyes with advanced glaucomatous damage have little residual reserve and small amounts of progression can have important consequences affecting patient’s visual function and quality of life. We propose optimizing the use of longitudinal optical coherence tomography macular data to confirm and predict functional progression. The results of the proposed study will lead to the development of more effective methods for earlier detection of glaucoma progression and will allow clinicians to more aggressively treat deteriorating eyes resulting in decreased visual disability and reduced rates of blindness from glaucoma. ! !